Project 3: Extending Clinical Benefit by Selective Treatment of Resistant Lesions in mCRPC

PROJECT SUMMARY
Development of treatment resistance is the main reason for disease progression in patients with mCRPC. What
is under-appreciated is that many patients who are experiencing progression have the majority of individual
lesions that continue to respond to therapy. Identification of resistant lesions would allow for administration of
localized ablative therapies, especially if the systemic therapy is still effective for the majority of metastases.
We hypothesize that selective treatment of resistant lesions (e.g. with stereotactic body radiation therapy) will
extend duration of clinical benefit in men with mCRPC. We will identify resistant lesions by employing our unique
advanced quantitative molecular image analytics - Quantitative Total Extensible Imaging (QTxI) which allows
lesion-level assessment of treatment dynamics. We will test our hypothesis through the following aims: (1) To
characterize resistance at early progression in men with mCRPC treated with second-generation androgen-
signaling inhibitors by employing QTxI of PET/CT starting at nadir PSA response, PSA progression, and again
in 12 weeks, (2) To conduct virtual selective radio-ablation study using different PET metrics for target lesion
selection of resistant lesions and to model impact of radio-ablation on total tumor burden and anticipated
improvement in clinical benefit and (3) To test clinical feasibility of radio-ablation using SBRT to selective
resistant lesions in a prospective therapeutic clinical trial.
This project is highly innovative as it explores lesion-level treatment resistance in mCRPC, uniquely
characterized by our technology, as a treatment target. Assessment of resistance at the time of clinical
progression is critical, as it triggers high anxiety in the patient and provider, and thus it is an urgent area of unmet
clinical need. We will conduct the first trial of its kind to identify and treat resistant lesions in the setting of wide-
spread metastatic disease with the goal of improving clinical benefit.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to leverage advantages of molecular imaging combined with advanced image analytics in order to identify individual patients with metastatic prostate cancer that may benefit from targeted ablation of individual resistant lesions in order to extend treatment benefit. The main outcome of our effort is optimization of the entire patient care continuum with existing treatment options.